Durability of a gene editing therapy that restores dystrophin in a humanized mouse model of Duchenne muscular dystrophy

Project Summary
Gene editing offers significant advantages for treating rare diseases since it edits the patient’s
own DNA. Thus, the normal regulatory environment of the gene is maintained, it can be used to
correct any gene regardless of gene size, and it generates edits that are expected to be more
durable than gene replacement approaches where loss of the episomal transgene may occur.
As next generation in vivo gene editing therapies advance towards clinical development,
preclinical studies are needed to assess long-term durability.
The gene editing therapy described in this application is designed to remove DMD exons 45-55
to restore the reading frame for 50% of Duchenne muscular dystrophy patients while retaining
87% of the protein coding sequence. This is ~3x more of the coding sequence than gene
replacement therapies which deliver a “micro-dystrophin” and introduces fewer non-native
junctions. It also replicates a patient genotype associated with no symptoms or just a very mild
disease course.
Thorough preclinical efficacy of this gene editing therapy has been demonstrated in an
established humanized mouse mode of Duchenne at 2 months post-treatment. In this proposal,
efficacy will be compared in long-term 6-month studies versus short-term 2-month studies.
Molecular and functional efficacy outcomes will assess DMD editing, vector copy number per
cell, restoration of both the DMD gene product (dystrophin) and the dystrophin-associated
glycoprotein complex, muscle histology, and muscle function testing using two different non-
invasive assessments. Multiple dosing strategies will be compared, including a two-fold higher
single dose and a repeat dose at Days 0 and 56. This work will clarify the long-term durability of
gene editing efficacy and how it is influenced by dosing regimens. Learnings from this proposal
will have wide applicability to other gene editing therapies which target post-mitotic tissues like
muscle. These data will be included in future IND filings and will help advance development of
an innovative gene editing therapy for Duchenne muscular dystrophy.

Public health relevance
Project Narrative In this project, the long-term durability of a gene editing therapy for Duchenne muscular dystrophy will be assessed in a humanized mouse model. The potential for long-lasting effect will be determined by comparing functional and molecular efficacy at 6 months versus 2 months. The proposed work will contribute towards development of an innovative gene editing therapy for the treatment of 50% of Duchenne muscular dystrophy patients.